REGULATION AND EXPRESSION OF THE UDP GLUCURONOSYLTRANSFERASE GENE FAMILY

This project follows up on the Section's previous description of the UGT1 locus, which has proven critical for the determination of genetic defects in Crigler-Najjar Type I (CN-I) patients. The complex (UGT1A - UGT1G) codes for at least 2 bilirubin (Br), 3 Br-like, and 2 phenol transferases. Seven different exon 1s, each with an upstream promoter and each encoding the amino terminus of an isoform, are arrayed in series with 4 common exons (encoding seven identical carboxyl termini) in the 3~ region of the locus. Predictably, a critical mutation in a common exon inactivates the locus; a deleterious mutation in an exon l as we describe for the UGT1A gene in two CN-I patients affects the amino terminus of that single isoform. The code in patient 1 for the predominant Br isozyme, the HUG- Br1 protein, is missing codon 170 (phe) in exon 1 of UGT1A abolishing a diphenylalanine in a conserved hydrophobic region A encoded by codons 161- 180. Studies with this mutant led to the discovery of the previously unknown major pH optimum (6.4) in contrast to the routinely used pH (7.6) which we show is only 1/3 as effective for Br glucuronidation using either HUG-Br1 protein or human liver microsomes. HUG-Br1-170, inactive at pH 6.4, has normal activity at pH 7.6, a result consistent with a pH- sensitive mutant. The HUG-Br1 protein and microsomes glucuronidate Br best at low ionic strength. The wild-type protein Km value for Br is 2.5 micromoles (pH 6.4 or 7.6); that for HUG-Br1-170 is 5.0 micromoles (pH 7.6). In the genome of CN-I patient 2, a point mutation (G-greater than C, gly to arg) at codon 276 abolishes a diglycine in a conserved region B encoded by codons 270-288 in exon 1 of UGT1A. The HUG-Br1-276, inactive at pH 6.4 and 7.6, defines micro-structure/region B which has 7 hydrophobic-, 7 amide-containing-, and 4 alpha-helix-breaking amino acid residues. Point mutations in common exons 2 and 4 of CN-I patients 3 and 4 with G->A (codon 309) and C->T (codon 376) uncovered conserved region C encoded by codons 298-315 and conserved residue D, ser/ala, respectively. In the common carboxyl terminus micro-regions C and D presumably interact with the common substrate, UDP-glucuronic acid, while hydrophobic regions A and B most likely interact with the lipophile-like Br substrate. Characterization of human transferase encoded by the UDPGTh-3 cDNA, establishes that it specifically glucuronidates the dihydrotestosterone and androstane diol steroids; its mRNA is located in testis and prostate, as well as liver, suggesting a critical role for udpgth-3 in target tissue. The absence of its mRNA, and the presence of that for four other isoforms in the liver of a patient with benign prostate hyperplasia (characterized by depressed glucuronidation of dihydrotestosterone) is supportive evidence for its biochemical importance.